PHASE II STUDY OF RECOMBINANT BETA AND GAMMA INTERFERON IN LUNG CANCER

This study will to determine the toxicity of combined recombinant interferon gamma and beta serine in patients with metastic non-small cell carcinoma of the lung; the response rate of this therapy as measured by disease-free survival and overall survival; the immune-modifying activity of this combined therapy as measured by induction of TNF; the expression of Class II HLA antigen on monocytes and the correlation of this to survival; the immune-modifying activity of this combined therapy as measured by induction of TNF; the expression of Class II HLA antigen on monocytes and the correlation of this to clinical response.